Metastasis and biophysics of clusters of circulating tumor cells in the microcirculation

ABSTRACT
Circulating tumor cells drive metastasis when they travel from primary tumors to distant organs via the
circulation. Multicellular clusters of circulating tumor cells though less frequently observed in blood, are
much more likely to establish metastases than individual circulating tumor cells and the presence of tumor
clusters in blood has been associated with dramatically worse prognoses in patients. Although there are
many suspected explanations for their greater metastatic potentials, much is still unknown about the
behavior of clusters, especially in the narrow vessels of the body. Recent evidence has demonstrated that
cluster transiting through narrow constrictions experience dynamic changes to structure and organization.
Forces in the microcirculation cause clusters to reversibly re-organize into single-file chains to enable
transit through narrow capillary-sized vessels and nuclear envelopes are ruptured and rapidly repaired
during migration events through narrow constrictions. Two biophysical parameters within clusters,
cellular adhesion strengths and nuclear mechanics, are vital for these behaviors. Because of the important
role that these parameters play in many aspects of metastatic progression, we hypothesize that these
parameters modulate the biophysical responses of clusters to physical forces in the microcirculation, and
that these interactions play a significant role in the competitive edge that clusters have edge over
individual cancer cells for seeding metastases. To this end, we propose three specific aims. In aim 1, we
will develop next generation models of the human microcirculation with rounded networks of endothelial
cell coated microfluidic devices and geometry matched computational simulations. In aim 2, we will
explore how intercellular adhesions affect the biophysical responses and metastasis-forming abilities of
homogeneous versus heterogeneous clusters in the microcirculation through the use of our developed
models. Finally, in aim 3 we will study the physical basis for nuclear envelope rupture, DNA-damage,
genetic instability and other DNA-level affects that are involved in metastatic progression. Understanding
the interplay between the biophysics and biology of clusters within the microcirculation will elucidate
mechanisms that can be used to combat the progression of cluster-initiated metastases.

Public health relevance
NARRATIVE Multicellular aggregates of tumor cells are potent initiators of the progression of cancer from localized tumors to multi-organ metastases by transiting through the circulation to establish metastases in distant organs. Recent evidence has shown that the forces applied to cancer cells while they travel through the smallest vessels of the body, cause dramatic changes to the behavior of adhesions and nuclei within clusters and that these forces may be responsible for the increased potency of aggregates vs. single tumor cells. We aim to study how physical forces interact with the biological components of clusters to initiate metastasis and to devise methods of combating it.